PHARMACOKINETIC STUDIES OF ANTIRETROVIRAL AGENTS

The objective of this project is to study the pharmacology and pharmacokinetics of antiviral drugs in vivo and to obtain information that will allow the design of a safe and efficacious dosing regimen for the drug. This is an ongoing project that will continue in the coming years.